DOCLINE Coordination Office (NDCO)

NN/LM DOCLINE Coordination Office Summary The University of Maryland, Baltimore (UMB) Health Sciences and Human Services Library seeks to establish and inaugurate a NN/LM DOCLINE Coordination Office (NDCO), an office that will collaborate and perform support nationally, centralizing a service that has been previously been performed by each region. UMB proposes four pillars of support: communication with network members via telephone, listservs, and social media (that may or may not be “owned” by NDCO) and with the NN/LM, day-to- day support and education via formal and informal methods, evaluation of the service to maintain efficiency and evaluation of the NDCO to ensure satisfaction and accomplishment, and continuity planning to ensure continued service.

Public health relevance
Project Narrative The NN/LM DOCLINE Coordination Office proposes to facilitate equal access to biomedical and health information to a variety of users including health professionals and lay persons. This will result in better health outcomes for the Southeastern/Atlantic region because health professionals will have the best evidence for decisions, health researchers will have the latest knowledge in their fields, and consumers may make informed decisions about their own healthcare and that of their friends and family.